Xavier RCMI Renewal Application--Community Engagement Core

RCMI Community Engagement Core (CEC) Summary
CEC, a Key Component of the Xavier RCMI Center is to facilitate meaningful community involvement to
ensure effective and trusted bi-directional relationship between researchers and community. Expanded use
of community-based participatory research (CBPR) has been noted as a “strategic imperative” to develop
effective interventions to address health disparities. Community Engagement is an essential component of
the research process. A review of the history of earlier population-based studies, in both majority and
minority populations, indicates that requisite to a study's success is the comprehensive involvement of the
study population's Community. The CEC will leverage the infrastructure and established community
networks established by the Louisiana Clinical and Translational Science (LACaTS) Center’s Community
Engagement and Outreach Resource (CEOR) Core. The CEC will embark on successful and impactful
community engagement strategies and activities by addressing the following four specific aims.
1. Promote and sustain community-academic partnerships through bidirectional knowledge sharing to
ensure that intervention strategies and scientific discovery in cancer health disparities and related risk
and protected factors are relevant to community needs and translated into community knowledge and
practice.
2. Facilitate greater community involvement in setting research priorities and creating more opportunities
for academic-practitioner-community research partnerships.
3. Build capacity (knowledge and skills) among research investigators, community members, health
systems, and potential research participants to conduct innovative and transformative research projects
to address community health needs, particularly in cancer research.
4. Provide support for investigators for developing appropriate strategies to facilitate dissemination of
research findings of the center to the scientific and community organizations, and lay communities.
To effectively engage and communicate with the community, CEC will employ the CBPR principles and
methods in ensuring the needs of the community are ascertained and addressed through research, health
promotion and education. CEC will serve as a liaison between (1) investigators and community – fostering
and nurturing a bi-directional relationship between academic researchers and community; and (2) internal
(Xavier) and external (LACaTs) investigators – for purpose of collaborative research and mentorship. The
CEC’s established trusted and sustainable relationships with the community will ensure its involvement of
the engagement continuum (Outreach, Consult, Involve, Collaborate, and Shared Leadership).